Prefrontal-cingulate functional networks in aging monkeys: neural circuit substrates of cognitive aging

Abstract
White matter degeneration and synapse loss in the frontal lobe are the most pronounced neural changes
associated with age-related cognitive decline
, but the extent to which these changes affect anatomical neural
circuits and network dynamics in vivo are largely unknown.
In recent human studies, correlated functional MRI
BOLD signal fluctuations found across anatomically related brain areas have been used to infer functional
“resting-state” network (RSN) connectivity, providing a promising non-invasive means to study the dynamics of
brain networks in vivo
. Deciphering the relationships between age-related changes in in vivo whole-brain network
activity and the cellular-molecular architecture is key to understanding cognitive aging and neurodegenerative
disease, such as Alzheimer’s Disease and Related Dementias (ADRD), in the human brain. The focus of this
project is on functionally-distinct prefrontal areas implicated in cognition and aging-- the
lateral prefrontal cortex
(LPFC),) and medial prefrontal anterior cingulate cortex (ACC)—which participate in distinct functional networks
and have diverse roles in cognitive processing. The ACC in particular has been implicated in controlling functional
network states and RSN whole brain dynamics to mediate flexible behavior, but the exact mechanisms are not
fully understood. The excitatory and inhibitory microcircuits within distinct prefrontal areas, and their extrinsic
pathways likely play an important role in shaping the dynamics of functional connectivity. However, in depth
anatomical and neurochemical cellular and molecular validation of in vivo MRI measures of connectivity and
microstructural integrity and how these properties change with age have not been assessed. This proposal aims
to unravel the properties of these anatomical circuits and their relationships with age-related changes in RSN
dynamics and cognitive decline in our well-established rhesus monkey model of normal aging. Using multimodal
MRI and cognitive testing, combined with single-cell transcriptomics, in vitro electrophysiology, neural tract-
tracing and high-resolution microscopy in young and aged adult rhesus monkeys (Macaca mulatta), we will
highlight features of age-related changes in distinct RSNs and their relationship to white matter integrity,
excitatory-inhibitory circuitry and extrinsic pathways in LPFC and ACC. We will use this large-scale multi-modal
MRI and microstructural dataset to build a computational machine learning framework that can define biomarkers
of cognitive aging. The overall hypothesis of this proposal is that functional and structural network
connectivity and excitatory:inhibitory (E:I) balance of LPFC and ACC areas are differentially altered with
age, in patterns that underlie specific aspects of age-related cognitive decline.
The proposed multimodal
studies will yield data that can be used to infer the neural substrates of human brain networks and predict how
they change across age. These data will inform development of novel functional imaging biomarkers for neural
circuit dysfunctions associated with cognitive impairments in aging, which can be extended to related
neuropsychiatric and neurodegenerative diseases.

Public health relevance
Narrative Two key frontal cortical areas implicated in cognitive aging —the lateral prefrontal cortex (LPFC) and anterior cingulate cortex (ACC) -- participate in diverse in vivo functional “resting state” networks, but the neural basis of in vivo MRI measures of connectivity and how they change with age has not been elucidated. Using multi-tiered in vivo and ex vivo methods, the proposed study will assess age-related changes in functional MRI resting state network dynamics and how these relate to cognitive decline, and cellular-molecular circuit properties in LPFC and ACC. Understanding these macro- to micro-scale relationships is essential to developing novel in vivo MRI biomarkers for neural circuit imbalances associated with cognitive impairments in aging, which can be extended to related neuropsychiatric and neurodegenerative diseases.